The origin, maintenance, and adaptive consequences of variation in genome structure

Project Summary/Abstract
Background: Understanding the origin and fate of genetic variation relies on accurate measurement of that
genetic variation. Until recently, whole genome sequencing approaches exhibited blind spots regarding vast
swaths of genomes comprising repetitive regions, despite repeated demonstrations of the importance of
mutations involving gene duplications, tandem duplications, TE insertions, and other structural changes that are
associated with repeats. Indeed, such mutations are often targets of adaptation, are associated with variation in
human traits, play causative roles in many genetic diseases, and often play key roles in important phenotypes
in species that coexist with humans (e.g. conferring pesticide resistance to human disease vectors). Despite this,
surveys of genetic variation typically continue to select techniques based on convenience and cost-effectiveness.
Indeed, even standard long-read sequencing approaches fail to recover >15% of the genome. A better way would
be to apply emerging methods capable of resolving all regions, particularly ensemble approaches combining
highly accurate and ultra-long sequencing technologies and long-range scaffolding techniques. Such
approaches have already proven capable both of reducing the uncertainty in inferring structural mutations and
of saving analysis time. Projects can now plausibly aim to obtain accurate, full genetic catalogs of each
chromosome, from telomere to telomere. Now is the ideal time to discover and make inferences on the full
spectrum of genetic mutations.
Proposal: The Emerson lab’s research focuses on the evolution of genome structure, particularly mutations that
add, subtract, or otherwise refashion genome sequence on large scales. We apply cutting edge sequencing,
computational, and statistical techniques to discover and interpret structural genetic variation in the most
recalcitrant regions in the genome, using Drosophila melanogaster as a model system. Over the next five years,
our goal is to identify all structural genetic variation in samples within and between species, infer the evolutionary
forces acting on them, and understand their functional consequences. We will adapt cutting-edge telomere-to-
telomere approaches to extend our reach into every region of the genome to obtain an exhaustive inventory of
genetic variation within and between species, eliminating the thorny problem of genotype-based ascertainment
bias and error in evolutionary inference. In doing so, we will develop tools to aid in genome assembly, structural
variant genotyping, and evolutionary analysis. We will also use functional genomics techniques to understand
how perturbing primary genome structure changes genome function. Finally, we will identify individual candidate
mutations for functional characterization using reverse genetics. With such comprehensive surveys of genetic
variation, we can finally meet the challenge of discovering all classes of genetic variation to study the evolution
of genome structure and function.

Public health relevance
Project Narrative The research proposed here uses Drosophila as a model system to investigate the consequences of variation in genome structure by employing state-of-the-art genomics techniques to discover genetic variation previously overlooked by older techniques. Such mutations are often in repetitive regions of the genome and, in humans, are often associated with traits important for human health and well-being, including disease causing mutations (like those often found in cancer or genetic diseases like Huntington's disease) as well as mutations common in disease vectors (like those that confer insecticide resistance in mosquitoes). This research will lead to a greater understanding of how genome structural changes impact evolution and the development tools to enhance discovery of such mutations.